Vasomotor and Sudomotor Activity During Heat Stress in Spinal Cord Injury

Sensory and motor impairment after spinal cord injury (SCI) is well studied and classified with international
standardized assessment tools. Meanwhile, autonomic impairment after SCI, is without a standardized clinical
assessment tool/exam, is challenging to treat and causes greater impairment in quality of life than paralysis
alone.1,2 One sequela of autonomic injury post SCI is thermal dysregulation. It is well accepted that persons
with spinal cord injury have impaired ability to regulate core temperature due to compromised thermoregulatory
vasomotor and sudomotor activity.3 In the setting of heat stress, impaired cutaneous vasodilation obviates skin
blood flow (SkBF) increases and prevents convective cooling while impaired sweating responses (SR)
prevents evaporative cooling. As a result, persons with SCI have difficulty maintaining thermal homeostasis,
especially under heat stress. Body cooling intervention trials performed to date have all proven minimally
successful likely due to lack of clear mechanistic understanding of autonomic change post-SCI. In non-SCI
persons, sympathetic cholinergic mechanisms that mediate efferent control of both SkBF and SR are
commonly thought to involve one and the same set of nerves; however, definitive proof is lacking. Indeed,
cholinergic vasodilator nerves and cholinergic sudomotor nerves could actually be anatomically separate.
Interestingly, it has been reported that during heat stress, persons with complete SCI have skin regions where
SkBF increases without concomitant SR increases and other regions where SR increases without concomitant
SkBF increases.7,8 These results suggest that efferent cholinergic sympathetic vasomotor nerves and efferent
cholinergic sympathetic sudomotor nerves are separate, rather one and the same. Being able to study
cholinergic vasodilator nerves and cholinergic sudomotor nerves in isolation in SCI will provide a valuable
model for thermoregulatory physiology studies in non-SCI and SCI persons, and guide next steps in
development of 1) An effective cooling technique so as to minimize heat related illness during exercise in the
SCI population with a high prevalence of cardiometabolic disease and 2) A more quantitative assessement of
thermoregulatory and autonomic function post-SCI to determine persons at greatest risk of its sequela.
OBJECTIVES - To define and test the neurological control mechanisms of sudomotor and vasomotor activity
after SCI to determine if their efferent cholinergic control is through an anatomically separate set of nerves. (1)
Map areas of vasomotor and sudomotor activity during heat stress in persons with SCI and compare
thermoregulatory level of injury (TLOI) with sensorimotor LOI. (2) Test whether increased noradrenergic
vasoconstrictor activity attenuates SkBF increases in regions that show SR increases but no SkBF increases
during whole body heat stress. (3) Test the hypothesis that cholinergic presynaptic nerve activity effects
vasomotor and/or sudomotor responses in regions with discordant SR and SkBF increases during whole body
heat stress. METHODS - 50 persons with chronic SCI and 25 AB persons will undergo passive heat stress and
areas of sudomotor and vasomotor activity will be outlined. Pharmacologic tests using bretylium iontophoresis
and onabotulinum toxin intradermal injections will be utilized to manipulate areas with concordant and
discordant vasomotor and sudomotor activity to determine the neurological control mechanisms in each area.
Areas of intact thermoregulatory function will be compared to areas of intact sensory and motor function.
IMMEDIATE AND LONG TERM CAREER GOALS - Dr. Trbovich's career goals over the next 5 years include
expanding her expertise and experience through the proposed research plan, structured training in research
skills and mentorship under experienced researchers and clinicians in the field. This opportunity will allow her
to develop necessary skills to compete for a VA Merit Review Award in the future. Her long-term goal is to
become a VA physician scientist with an independently funded research program that will allow her to
significantly contribute to current unanswered questions in the field of autonomic dysfunction after SCI.

Public health relevance
The mission of the Spinal Cord Injury (SCI) and Disorders Centers of the Veteran's Health Administration, is to “support, promote, and maintain the health and quality of life of individuals with SCI throughout their lives.” SCI not only results in physical paralysis but also results in autonomic dysfunction that causes even greater impairment of quality of life. Thermal dysregulation, one consequence of autonomic dysfunction, impairs sweating and increased skin blood flow that both cool the body during heat stress. Persons with SCI often avoid exercise due to discomfort from overheating and there is no known effective cooling technique. Exercise is essential to prevent heart disease, diabetes and obesity that are each more prevalent in SCI than non-SCI persons; with heart disease, being the most common cause of death. These studies will use pharmacological tests to elucidate the neurological mechanisms of impaired sweating and skin blood flow so cooling interventions and autonomic tests can be developed to improve the health and quality of life of SCI persons.